MOLECULAR MECHANISMS OF AUTOIMMUNE DISEASE IN MAN AND ANIMAL MODELS

We are studying the cellular and molecular basis of autoimmune diseases with two purposes. First, we want to establish the pathogenic role and antigen-specificity of T cells that cause autoimmune diseases such as multiple sclerosis, myasthenia gravis, insulin-dependent diabetes, among others. Second, we would like to determine the feasibility of specific antigen-induced apoptosis as a means of treating such autoimmune diseases. To these ends, we have made progress in the following areas: 1) we have employed the marmoset model of experimental allergic encephalomyelitis to show that determinant spreading is an important event in generating immune responses that cause damage to the myelin sheath; 2) we found that repeated administration of a protein component of the insulating sheath (myelin) of nerves in the central nervous system dampens the immune response and improves clinical outcome in marmosets; 3) we are continuing to progress towards a clinical trial of antigen-induced apoptosis in multiple sclerosis, and 4) we have created a transgenic mouse model of myasthenia gravis which has a powerful response to a peptide from the acetylcholine receptor. As part of these studies we are also trying to understand the regulation of antigen-induced death by T cell receptor stimulation. These studies should yield important new insights into the pathogenesis and treatment of autoimmune diseases which is a widespread health problem in the U.S. particularly among working women. - Autoimmunity, multiple sclerosis, myastenia gravis